Washington University Institute of Clinical and Translational Sciences

Contact PD/PI: Powderly, William G.
Overall Component, 7. Project Summary/Abstract:
The Institute of Clinical and Translational Sciences aligns with the CTSA goals of developing innovative
solutions to improve the efficiency, quality, and impact of translational science. We will pursue five aims:
Aim 1: Advance interdisciplinary programs to develop, promote, mentor, and retain highly qualified
and diverse faculty, trainees, and staff who translate scientific discoveries into action, thereby
becoming agents for change in their institutions and communities. We will enhance our existing research
education and training programs, expand and diversify our workforce, and promote team science approaches
to conduct and translate high-impact research that has the potential for changing the health of our community.
(Translational Workforce Development).
Aim 2: Facilitate research designed for implementation by engaging diverse communities and
stakeholders in multidisciplinary collaborative teams at all stages of the translational research
process, thereby demonstrating the benefit and impact of translational science. We will improve
community health by collaborating with patient advocates, developing new partnerships, advancing the science
of collaboration, and capitalizing on strengths in implementation science (Collaboration and Engagement).
Aim 3: Integrate research across individual lifespans and apply translational science in complex and
diverse populations to improve individual and community health through meaningful research
collaborations and sustainable partnerships. We will address health disparities across the lifespan and
among special populations, identify challenges that differentially affect urban and rural populations, catalyze
the formation of transdisciplinary teams, and evaluate the outcomes of our work (Integration).
Aim 4: Drive innovation, quality, efficiency, and inclusion in translational research to enhance
collaborations and catalyze the implementation of discovery science. We will solve key logistical
roadblocks in translational science and implement innovative methods to engage stakeholders and research
participants, thereby targeting different populations, life stages, and health states (Methods and Processes).
Aim 5: Apply innovative informatics and biostatistics solutions to improve quality and efficiency at
every stage of translational research, and create an ecosystem that integrates diverse data and
facilitates the interoperability, use, and reuse of digital assets. We will ensure the interoperability of
current and archived data sets, implement new informatics technologies to enhance investigator productivity,
and promote the formation of interdisciplinary research teams (Informatics).
Impact. Successful completion of these five aims will transform translational research, accelerate the
dissemination of new innovations across our entire population, and strengthen and diversify our workforce.
Project Summary/Abstract Page 235
Contact PD/PI: Powderly, William G.
Overall Component
8.

Public health relevance
Project Narrative: The overall goal of this proposal is to accelerate advances in human health by engaging multiple stakeholders in the translation of scientific discoveries to drive improvements in health and reduce inequity among diverse populations. Our proposal will improve clinical research through high quality and efficient methods/processes, develop a trained workforce skilled in team science, and disseminate research findings into real-world implementation to improve health and healthcare for patients, our diverse communities, and our nation. Project Narrative Page 236